Immune mechanisms that shape the blood brain barrier in people living with HIV and cocaine use disorder

PROJECT SUMMARY/ABSTRACT
The blood brain barrier (BBB), formed by vascular endothelial and supporting cells, functions to regulate blood-
brain exchange of substances and cells, and to protect the central nervous system (CNS) from neurotoxins and
pathogens. Building on our efforts toward ameliorating HIV-associated CNS complications and achieving HIV
cure, we now must address the growing evidence that BBB impairment is associated with acute and/or repeated
cocaine use
. Cocaine misuse (intranasal, intravenous, inhalation) is common
among people living with HIV
(PLWH) and viral reservoirs in brain can be seeded by infected immune cells that penetrate the BBB
. As the field
pursues new strategies to mitigate CNS consequences of HIV infection in the context of substance use, and
achieve cure, it will be critical to define the mechanisms by which HIV-infected cells and cocaine impact BBB
integrity and the subsequent consequences on both the viral reservoir and cognition in PLWH. We
propose a
central model wherein historical cocaine misuse causes a persistent deficit in BBB integrity that underlies
cognitive impairment in PLWH. In this model, PLWH with historical cocaine use disorder (CUDH) 1) have higher
prevalence of CCR2+ALCAM+ intermediate monocytes that harbor HIV proviral DNA and migrate to the brain,
and 2) this higher prevalence of CCR2+ALCAM+ intermediate monocytes results in increased transmigration
across the BBB disrupting BBB permeability and tight junctions (TJ).
In vivo studies in humans have not assessed
CUDH
and long-term BBB integrity in PLWH. The recent development of the Water-extraction-with-phase-
contrast-arterial-spin-tagging (WEPCAST) MRI sequence facilitates in vivo measurement of BBB permeability to
small molecules without contrast. We propose using WEPCAST MRI to assess BBB integrity in vivo in 175 PLWH
with CUDH
and 75 PLWH without CUDH. We will determine the effect of immune cell phenotypes, HIV proviral
DNA burden and in vitro alterations to BBB TJ on in vivo BBB integrity in PLWH with and without CUDH. Aim
1: Determine the contribution of immune cell phenotypes to BBB permeability in PLWH with and without CUDH.
We will assess BBB permeability via WEPCAST in relation to monocyte and T cell phenotypes implicated in
transmigration of activated cells across the BBB. Aim 2: Determine the contribution of immune cells harboring
HIV proviral DNA to BBB permeability in PLWH with and without CUDH. We will assess HIV proviral DNA via the
Intact proviral DNA assay (IPDA) in monocytes and CD4 T cells in relation to BBB permeability via
WEPCAST. Aim 3: Determine mechanisms by which monocytes that harbor HIV proviral DNA increase BBB
permeability in PLWH with CUDH. We will assess BBB permeability using an in vitro model of the BBB to elucidate
how HIV infected monocytes shape BBB tight junctions.
Our in vivo study utilizing a noninvasive BBB integrity
measure combined with immunophenotyping, reservoir analysis and a mechanistic approach to determine the
effect on BBB TJ are highly innovative. Data will provide support for addressing BBB integrity in PLWH with
CUDH and guide investigation of therapeutics aimed to promote BBB health in substance use disorders.

Public health relevance
PROJECT NARRATIVE Cocaine misuse is common he heath of the blood brain among people living with HIV (PLWH) and can affect t barrier (BBB), which protects the brain from neurotoxins and pathogens. The disruption of the BBB can lead to higher levels of virus in the brain and poorer cognition. This project combines brain imaging, neuropsychiatric assessments, and blood-based measures of monocyte characteristics, function and reservoir, to understand the role of monocytes play in BBB integrity and health in PLWH who have a history of cocaine misuse.